UCSF-Kaiser Department of Research Building Interdisciplinary Research Careers in Women's Health (BIRCWH) Program

ABSTRACT
This administrative supplement proposes K12 and postdoctoral scholar funding for the University of California,
San Francisco (UCSF) and Kaiser Permanente Northern California (KPNC) Division of Research’s Building
Interdisciplinary Research Careers in Women’s Health (BIRCWH) Program. Program objectives are to:
1. Recruit a superb and diverse group of early-career women’s health researchers;
2. Provide tailored training and mentoring on sex and gender influences in health and disease;
3. Build upon our existing program by targeting topics in women’s health of public health importance;
4. Strengthen and integrate models of interdisciplinary research to develop researchers who foster
linkages across disciplines and institutions and excel in building team science; and to
5. Promote the prominence of women’s health and the retention of investigators underrepresented in
clinical research by mentoring BIRCWH scholars and alumni in academic advancement and leadership.
The rationale of our program is that scholars’ successful careers in women’s health will transform biomedical
research and ultimately advance women’s health and improve health equity in the US through sustained focus
on the study of sex and gender influences in health and disease. The program brings together mentors and
advisors from 16 UCSF departments and centers and from KPNC and emphasizes interdisciplinary
approaches to a wide range of women’s health issues. We will continue the program’s initiatives in path-
breaking research in women’s cancers; environmental health; mental health, addiction, and cognition;
infectious diseases; metabolism and bone health; and reproductive health across the lifespan. A UCSF/KPNC
Advisory Committee oversees the program in partnership with leadership, along with newly appointed external
advisory members for greater outreach to underrepresented scholars. Our program is strengthened by
mentoring teams that cross disciplines and with our newly offered training in mentoring across differences.
Diverse scholars and faculty—in terms of fields of interest, background, training, race/ethnicity, and gender—
are a priority. We connect scholars to a network of our BIRCWH scholars and alumni, including investigators
underrepresented in medicine for ongoing peer and mentor support. Our BIRCWH scholars receive tailored
mentoring, and participate in training courses, program seminars, progress assessments, and leadership
development activities. An array of career development and training opportunities at the UCSF Clinical and
Translational Science Institute (CTSI) support our BIRCWH program. The career development path for each
scholar is tailored to the specific experience and mentoring that will most effectively support transition to
independence. Our program evaluation follows a conceptual framework of important domains to scholar career
development, with survey measures that assess scholar outcomes such as career trajectory, scientific
productivity, and BIRCWH program effectiveness for up to 10 years afterwards.

Public health relevance
Project Narrative The UCSF-KPNC Building Interdisciplinary Research Careers in Women’s Health (BIRCWH) Program offers mentored training to scholars to advance women’s health and health equity in the U.S. through the study of sex and gender influences in health and disease. This proposal will directly support the career development of a scholar underrepresented in medicine and help to strengthen a diverse scientific workforce in women’s health research. It will also provide support for a postdoctoral scholar, increasing focus on significant public health issues in women’s health. The program strengthens interdisciplinary research skills and trains women’s health researchers for successful careers in team science focused on topics of public health importance, ultimately improving U.S. health outcomes and health equity.